The Impact of Sleep Disordered Breathing in People who use Opioids

Project Summary/Abstract
This proposal details a five-year research and career development plan for Jeremy E. Orr, M.D., a specialist in
pulmonology and critical care medicine, and Assistant Professor of Medicine at the University of California, San
Diego. His research has been supported by a National Research Service Award fellowship and currently an
American Thoracic Society Foundation award. The overall focus of his research is understanding the importance
of breathing issues during sleep in patients using chronic opioid medications, and identifying treatment strategies
for these complex breathing issues that will improve health. This K23 award will provide necessary support for
Dr. Orr to gain expertise in patient-oriented clinical research, applied physiology of sleep disordered breathing,
and clinical trials. Dr. Orr has assembled a comprehensive team of mentors to support his research and career
development. His primary mentor, Dr. Atul Malhotra, is a world expert in sleep disordered breathing (SDB) and
applied respiratory physiology, with a strong track record of mentoring and promoting junior faculty to become
independent investigators. Dr. Robert Owens is a NIH-funded physician-scientist with expertise in advanced
techniques to measure SDB physiology, and will serve as a “hands-on” co-mentor. Additional members of the
team are Dr. Sonia Jain (statistics and trials), Dr. Mark Wallace (opioids and pain), Dr. Shamim Nemati (signal
analysis), and Dr. Frank Powell (control of breathing). Patients with chronic pain who use chronic opioids are at
increased risk for poor health including ongoing pain, poor sleep, decreased quality of life, and an increased risk
of mortality. Opioids are known to have effects on breathing which may lead to SDB, an under-recognized factor
potentially contributing to adverse outcomes in these patients. SDB contributes to sleep disruption and
impairments in oxygen levels, but has been little studied in this high-risk group of patients using opioids. In a
broad group of subjects with chronic pain who use chronic opioids, this research will determine whether treatment
of SDB with continuous positive airway pressure (CPAP) leads to improved sleep quality, as well as investigating
other symptoms including pain in these patients (Aim 1). CPAP treatment may not be effective in some patients
due to unstable breathing (due to opioids), so techniques to identify such individuals will be investigated,
including new measures of breathing instability. For patients with persistent SDB despite CPAP, treatment
options are limited. The research will evaluate whether a medication (acetazolamide) that helps to reduce the
instability of breathing will help to resolve SDB (Aim 2). This research will provide Dr. Orr with a strong foundation
to become an independent investigator studying the impact, pathogenesis and treatment of SDB in those using
chronic opioids.

Public health relevance
Project Narrative Opioid use has greatly increased in recent decades and has been characterized as a public health crisis. Even amongst those using prescription opioids under physician supervision for chronic pain, these medications may lead to adverse effects, potentially by contributing to breathing issues during sleep. The goal of this research is to understand how these breathing issues might affect patients using opioids, as well as to help identify treatments that will improve symptoms and potentially decrease the risk of poor health outcomes.